Core 2: Biostatistics and Bioinformatics

Core 2: Biostatistics and Bioinformatics - SUMMARY/ ABSTRACT
The primary goal of the University of Texas MD Anderson Cancer Center SPORE in Hepatocellular Carcinoma
(HCC) is to facilitate innovative translational research through the elucidation of underlying molecular
mechanisms, characterizing novel biomarkers and functional pathways, and exploiting novel targets for
treatment. This is a collaborative effort that will accomplish these aims by integrating laboratory and
translational research. The Biostatistics and Bioinformatics Core will serve multiple needs for the planning and
conduct of the SPORE's research. Based on a strong track record for providing biostatistical and
computational support for translational research, Core 2 will be a comprehensive, multi-lateral resource for
designing clinical and basic science experiments, performing statistical analyses, developing innovative
statistical methodology, and publishing the research results generated from this HCC SPORE. Core 2 will
provide guidance in the design and conduct of clinical trials and other experiments arising from the ongoing
research of the SPORE, including SPORE projects, Developmental and Career Enhancement projects, and
other cores. Core 2 will also provide biostatistical and bioinformatic modeling, simulation techniques and data
analyses needed by the Projects and other Cores to achieve their Specific Aims. Core 2 will generate statistical
reports for all projects, will assist project investigators to publish scientific results and will develop innovative
statistical and bioinformatics methods pertinent to translational HCC studies including new unsupervised
approaches to biomarker signature construction.

Public health relevance
Core 2: Biostatistics and Bioinformatics - NARRATIVE The Biostatistics and Bioinformatics Core (Core 2) will serve as a comprehensive, multilateral quantitative resource to all project investigators for hypothesis refinement, design of clinical and pre-clinical studies, data acquisition and management, statistical and bioinformatics analysis, and careful and proper interpretation of results in all subsequent publications. Our involvement will ensure studies are properly designed to achieve the stated scientific goals, appropriate analytical tools employed that make use of the full information in the data, and data and analysis steps thoroughly documented to ensure results coming from the SPORE are rigorous and reproducible.